Screening of Above Elbow Amputees for Advanced Prosthetic Devices

RELEVANCE: This study will further characterize the patient satisfaction, biomechanics, limb kinematic
capabilities and residual limb anatomy of individuals with above elbow amputation (AEA) for use in the research
and development of advanced prosthetic technologies. This work aims to specifically evaluate individuals with
AEA treated with an osseointegrated (OI) prosthesis to make direct comparison between AEA OI and socket
users to improve our understanding of the overall impact of this new technology on Veterans amputees. Dr.
Sarina Sinclair and her team have the clinical research foundation on which to successfully complete this work.
Direct skeletal attachment of prosthetic limbs through osseointegration, is currently being tested and
optimized at the George E. Wahlen VA Salt Lake City Health Care System and implemented by our collaborators
at Atrium Medical Center. OI technology is being developed to improve prosthetic attachment, improve functional
outcomes and reduce complications commonly associated with socket interface systems. Our research team
has successfully developed an OI prosthesis in Veterans with transfemoral amputation. The knowledge gained
from our successful transfemoral OI program is now being applied to AEA. It is our goal to offer individuals with
AEA enhanced data on OI systems that will enable them to make informed decisions on these upper extremity
prosthetic technologies that have been developed in recent years to maximize function. This study will build upon
of the dataset we have previously collected from AEA socket users (detailing comprehensive anatomical, quality
of life, and limb kinematic data from individuals using socket technology) by comparing these data with the data
that we will collect from individuals with OI devices.
AIMS: Aim 1) Conduct in-person functional assessments of AEA participants being treated with an OI
prosthesis for comparison to a previously collected dataset of AEA participants using socket prostheses.
Aim 2) Characterize the residual limb anatomy of individuals with AEA treated with OI prostheses.
METHODS: Our team of investigators will capture limb kinematics, function, and satisfaction data from an AEA
cohort treated with any OI device utilizing validated tools. Data from this new patient cohort will be directly
compared to our dataset previously collected from AEA socket prosthetic users. We will collect kinematic and
kinetic data from the AEA cohort treated with an OI device performing advanced activities of daily living. This
OI patient specific motion capture data will examine differences in limb kinematics between their intact and
amputated limb when using a prosthesis. Secondary outcomes will also investigate the impact of an OI
prosthetic suspension system on proprioceptive targeting motion and pain. Extended physiological
proprioception (EPP) assessments will be conducted from OI prosthetic users for direct comparison to: a) their
intact limb; and b) data previously collected from an AEA socket suspension cohort.
In Aim 2, we will collect calibrated radiographs, DEXA, and quantitative CT scans of the amputated and
contralateral limbs of individuals with AEA being treated with an OI prostheses to quantify bone health
parameters (cortical thickness, bone tissue percent, and bone mineral density). Comparisons will be made to
their intact contralateral limbs. Descriptive statistical analysis will assess for correlations of bone parameters with
age, time since amputation, prosthetic usage, and function.
SIGNIFICANCE: This work has the potential to significantly improve VA clinical care for amputees by advancing
the knowledge of how OI devices that are now being offered as alternatives to socket prostheses affect
biomechanics, function and patient satisfaction. This work will provide patients and providers with data to
better support informed decision making about new prosthetic technologies.

Public health relevance
Individuals with above elbow amputation (AEA) commonly reject the use of prosthetic limbs due to complications with the socket and harness suspension system. A direct skeletal attachment system for prosthetic limbs, known as osseointegrated (OI) prosthesis, have been developed for AEA to improve prosthetic satisfaction, function, range of motion, and wear time as compared to current socket systems. This investigation will utilize an AEA database created by our group to compare functional metrics between individuals with AEA who utilized socket technology to those who have received an OI prosthetic device. This study will provide a better understanding of functional differences between socket and OI devices in patients with AEA as functional limitations, and upper body movements. This work will also be used to expand characterization of residual limb anatomy, biomechanics, and functional capabilities of individuals with AEA.